New York Regional Center for Diabetes Translation Research

Enrichment Program
The Enrichment Program of the New York Regional Center for Diabetes Translation Research (NY-CDTR) will
serve as command central for coordination of enrichment activities that will include ‘Works in Progress’
seminars and research mentoring, special lectures, seminar programs, workshops, and live and virtual
education in type 2 to 4 (T2 to T4) translation research methods. We take very seriously our leadership role in
translation research in diabetes and see enrichment as a major venue to bring talented diabetes and related
research investigators together within the institutions, across institutions in the surrounding region, and
connected to our Latino Network for Diabetes Translation Research. In alignment with the health equity goals
of the NY-CDTR, the Enrichment Program provides enrichment activities that highlight the work and expertise
of the diverse and talented diabetes and obesity-related research investigators in our member network. The
specific aims of the program are: 1) to strengthen a novel mentoring program in which all Pilot & Feasibility
awardees receive faculty support and guidance during conduct of their studies, and participate in “Works in
Progress” seminars; 2) to facilitate access to various education and training enrichment activities (live and
online) covering T2-T4 translational research topics in diabetes prevention and control and related metabolic
disorders; 3) to facilitate networking among NY-CDTR members through media relations, publications,
multimedia, social media, internal communication, web and interactive media, and creative services to meet
membership collaboration and disseminate research findings and enhance collaboration throughout NY-CDTR
membership; and 4) to increase support resources for Underrepresented in Medicine (URiM) investigators and
enhance diversity in participation and outreach within the Enrichment Program. The aims of the Enrichment
Program are accomplished by the following: (a) Sponsor or co-sponsor guest speakers on relevant topics to
diabetes and obesity translation research; (b) Leverage enrichment activities (e.g., courses, workshops) from
other NIH-funded Centers at Einstein, and regional partners, in order to provide high level educational, training
and enrichment offerings to NY-CDTR members in the NY region; (c) amplify the work of our members and
connect to a broader audience across the translation research spectrum using the Einstein-Montefiore
Department of Communications and Public Affairs; and d) partner with the Einstein Office of Diversity and
Inclusion; and Office of Grant Support to leverage their resources to increase diversity and inclusion in our
programming.